Lymphocyte and inflammatory cytokine markers of response in the first-in-human combination of anti-PD-1 mAb and IL-15/IL-15Ra complexes and investigation of mediators of anti-tumor immune responses

Because PD-1 therapies only benefit approximately 1 in 5 patients with NSCLC, there is a great
need to improve immunotherapy for this disease. A distinct form of immunotherapy, IL-2, can yield complete
responses in melanoma and renal cell carcinoma. Use of IL-2 is limited due to common life-threatening toxicity.
An alternative to IL-2 is IL-15/IL-15Rα complexes. ALT-803 is a clinical grade IL-15/IL-15Rα complex and
powerful super-agonist for IL-15 responsive CD8+ lymphocytes and natural killer (NK) cells with dramatically
improved safety compared with IL-2. Preclinical studies combining ALT-803 with anti-PD-1 mAb demonstrate
remarkable anti-tumor efficacy associated with expansion of both CD8+ T cells and NK cells, and the production
of inflammatory cytokines such as IL-6 and IFNγ. We have moved this therapy into the clinic with an investigator-
initiated, first-in-human, phase Ib/II trial testing the clinical hypothesis that adding IL-15/IL-15Rα complexes (ALT-
803) to anti-PD1 mAb (nivolumab) is safe and efficacious in NSCLC (NCT02523469). To date 11 patients have
been treated with three highly active dose levels (6, 10, 15 mcg/kg SC, 15 being the highest planned dose) with
zero observed dose limiting toxicities (DLTs) and excellent activation of CD8+ T cells and NK cells and increases
in serum IL-6 and IFNγ. The goal of this application is to determine the mechanistic basis and predictors of
response for this promising combinatorial approach using our unique bank of trial-derived samples and a
powerful preclinical lung tumor model. We hypothesize that the addition of IL-15/IL-15Rα complexes to anti-PD-
1 mAb augments anti-tumor efficacy through enhanced expansion and functional activation of tumor-reactive
CD8+ lymphocytes and NK cells and that the induction of inflammatory cytokines such as IL-6 and IFNγ will be
associated with anti-tumor efficacy. We further hypothesize enhanced anti-tumor efficacy will depend on effector
lymphocytes (CD8+ and NK but not CD4+) and correlate with cytokines (IL-6 and IFNγ). Specific Aim 1: Using
state-of-art mass cytometry we will perform the high-dimension characterization of both NK and CD8+ T cell
compartments from longitudinal PBMC samples of up to 116 patients. We will perform TCR sequencing on
expanded T cells to determine if they originate from tumor. We will also perform 65-plex serum
cytokine/chemokine analysis of longitudinally acquired samples to identify novel serum biomarkers. We will
associate changes in lymphocyte and serum cytokines/chemokines parameters with clinical response. Specific
Aim 2: We will use our Lewis lung carcinoma (LLC) mouse model to inform our future clinical efforts with the
combination of anti-PD-1 mAb and IL-15/sIL-15Rα complexes. First, we will identify cellular and molecular
markers that correlate with treatment outcome using longitudinal analysis of responding and non-responding
mice. Second we will validate critical pathways using antibody-mediated depletion of lymphocyte subsets or
cytokines. Finally, we will evaluate the effects of alternate dosing and schedule on key effector populations, and
also integrate anti-CTLA-4 mAb therapy into our treatment.

Public health relevance
The grant application requests the funds needed to perform a sophisticated immune analysis of the patient blood and tumor samples of clinical trial specimens with the goal of understanding relevant mechanisms and identifying biomarkers that may predict patients that are likely to respond to therapy. Importantly, funding of this grant application would provide the investigators with protected time to analyze an incredible wealth of data that is expected to be generated.